Single Cell Core

SINGLE CELL CORE: PROJECT SUMMARY
The Single Cell Core will provide state-of-the-art experimental technology for single-cell multi-omic profiling. Two
major limitations of conventional scRNA-seq for immunophenotyping include the lack of correlation between
mRNA levels and surface protein expression and the lack of clonal identity from immune receptor sequence.
The Core will provide access to technologies for simultaneous profiling of mRNA, immune receptor sequence,
and surface protein expression from individual cells at scale. For experiments with limited cell numbers, we will
also provide scPLATE-seq, a fully automated platform for index sorting and scRNA-seq that is cost-effective for
low cell numbers. Given the focus on analyzing virus-specific immune responses longitudinally and across
tissues, the ability to associate immunophenotypes such as surface protein expression, the transcriptome, and
TCR sequence with antigen specificity is also highly desirable. This information will allow us to determine the
phenotypic subset and clonal identity of each cell in a virus-specific T cell population, to anchor virus-specific T
cells from different individuals, ages, and tissue sites to our reference map, and to investigate their functional
capacities with single-cell resolution. The Core will provide scalable technology for associating antigen specificity
and T cell receptor sequence with targeted mRNA and surface protein profiles of individual cells (TetTCR-
seqHD). We will develop and optimize barcoded tetramer pools for a broad range of viruses and vaccines
including CMV, influenza, and SARS-CoV-2 for joint analysis T cell receptor antigen recognition, clonotype,
and immunophenotype in individual T cells.